BAF60c and abdominal aortic aneurysm

PROJECT SUMMARY/ABSTRACT
Abdominal Aortic Aneurysm (AAA) is a primary medical concern due to the increasing prevalence and high
mortality rate upon rupture. Although vascular inflammation, extracellular matrix (ECM) degradation, and
subsequent vascular smooth muscle cells (VSMCs) apoptosis are pathologic features and drivers of AAA,
efforts to manipulate these processes did not yet result in any effective drug therapies beyond primary
prevention, creating an urgent need for new drug-based therapeutic strategies. This will be facilitated by a
deeper and comprehensive understanding of the molecular and cellular mechanisms driving onset,
progression, and outcomes of AAA. Chromatin remodeling altering gene expression has been linked to most
pathophysiologic conditions, including atherosclerosis and diabetes, but its role in AAA remains largely
unknown. The BAF60 family comprises three mutually exclusive subunits of the SWItch/Sucrose Non-
Fermentable (SWI/SNF) chromatin remodeling complex. Of relevance to the cardiovascular field, they play
essential roles in controlling lipid homeostasis, energy metabolism (BAF60a), granulocyte (BAF60b) and heart
(BAF60c) development. We found that BAF60a, b and c are differentially expressed in human and mouse AAA
tissues, suggesting a potential role of the BAF60 subunits in VSMC biology and the development of AAA. We
recently reported that loss of BAF60a in VSMCs prevents experimental AAA by reducing vascular inflammation
and ECM degradation in mice. Remarkably, BAF60c is the most abundant BAF60 subunit expressed in VSMC.
Our preliminary data show that BAF60c is downregulated in the abdominal aortic aneurysmal tissue in both
humans and mice. VSMC BAF60c knockout significantly aggravates elastase-induced AAA, and knockdown of
BAF60c in human aortic smooth muscle cells reduced the SMC contractile protein expression and increased
inflammatory genes and MMP9 expression. We hypothesize that VSMC-specific BAF60c attenuates AAA
development by maintaining the VSMC contractile phenotype, and inhibiting vascular inflammation and ECM
degradation. Using gain- and loss-of-function in HASMCs in vitro, AAA-relevant stimuli, our unique VSMC-
specific BAF60c knockout and transgenic mice, two established murine AAA models in vivo, and an integrated
workflow, we will (Aim 1) Demonstrate that VSMC-specific BAF60c attenuates AAA formation with attention to
altered cellular profiles and intercellular cross-talk by scRNAseq and provide proof-of-concept for therapeutic
targeting and (Aim 2) Determine the protective mechanisms of BAF60c in VSMC homeostasis in vitro using
relevant stimuli and RNAseq, ChIP-seq and co-immunoprecipitation. This work will provide unique mechanistic
insights on how various and varying risk factors translate into VSMC dysfunction leading to AAA and provide
the basis for developing novel therapies for AAA.

Public health relevance
PROJECT NARRATIVE Although abdominal aortic aneurysm (AAA) is a primary medical concern due to the increasing prevalence in older people and a very high mortality rate upon rupture, there are no effective pharmaceutical treatments for AAA to date. We propose to define the protective roles and underlying molecular mechanisms of vascular smooth muscle cells specific BAF60c in the development of AAA, which will set the basis to target BAF60c or its downstream factors for AAA treatment.